Mentoring Imaging Research in Early AD

DESCRIPTION (provided by applicant): This is a revised application for a K24 Midcareer Investigator Award in aging and Alzheimer's disease (AD) patient-oriented research. The candidate, Reisa A. Sperling, M.D. M.MSc., is an Associate Professor of Neurology at Harvard Medical School with a strong early track record as a productive clinical investigator and research mentor. The overarching aims of the candidate's research program are to: 1) elucidate the neural underpinnings of memory impairment in aging and early AD, 2) link the pathophysiological process of AD to the early clinical manifestations, and 3) develop sensitive imaging markers to track the progression of AD in the preclinical stages, enabling earlier intervention with disease-modifying treatments. The candidate has several ongoing NIH and foundation-funded multimodality imaging research projects in MCI and early AD, as well as a pending Program Project on aging and amyloid, which was recently very favorably reviewed. The applicant will use her funded research as a platform for the mentorship of new patient-oriented investigators and to promote a multidisciplinary research approach to the study of cognitive aging and early AD. The applicant's mentees will have the opportunity to train in functional, structural, and molecular imaging techniques, cognitive neuroscience, neuropsychological assessment of early dementia, biostatistics, and epidemiological aspects of longitudinal study design as they apply to aging and AD patient research, drawing expertise from an outstanding group of collaborators. Trainees will also be able to participate in research seminars, statistical training and imaging workshops provided by T32 and other training grants, career development and grant- writing workshops as part of the newly funded CTSA at Harvard, and didactic course work at Brigham and Women's Hospital, Massachusetts General Hospital, Massachusetts Institute of Technology, and the Harvard School of Public Health. The candidate herself will acquire additional expertise in advanced statistical and epidemiological methodology related to her ongoing research, and will expand her research into resting functional connectivity techniques as part of new research proposed for the K24 award. The K24 will be instrumental in advancing the candidate's research career in neuroimaging of early AD, and in protecting her time to mentor a new generation of investigators committed to AD patient-oriented research.

Public health relevance
PUBLIC HEALTH RELEVANCE: The applicant's research program seeks to understand the cause of memory problems in older individuals, to develop imaging tools to detect the earliest signs of Alzheimer's disease (AD), and to use these imaging tools to find effective treatments for AD. The applicant will use the K24 award to expand her imaging research program and to train new investigators for clinical research careers in patient-oriented AD research. NARRATIVE The applicant's research program seeks to understand the cause of memory problems in older individuals, to develop imaging tools to detect the earliest signs of Alzheimer's disease (AD), and to use these imaging tools to find effective treatments for AD. The applicant will use the K24 award to expand her imaging research program and to train new investigators for clinical research careers in patient-oriented AD research. __SpecificAimsTextDelimiter__ Specific Aims and Hypothesis for New K24 Research Converging evidence from multiple imaging modalities suggest that the pathophysiological process of AD disrupts large scale brain networks supporting higher order cognitive function, including memory, executive function and language. Recent studies in healthy young subjects have demonstrated that these networks exhibit intrinsic functional connectivity, detectable even in the resting state (Fox 2005; Vincent 2006; Kahn 2008). Of particular relevance to aging and early AD, is the integrity of network connectivity among in a set of regions compromising the “default mode network” (Raichle 2001). Disruption of default network connectivity has been reported in MCI and AD (Greicius 2004; Sorg 2007; Bai 2008) but also in normal aging (Damoiseaux 2008), even in the absence of amyloid pathology (Andrews-Hanna 2007). Thus, it is not yet clear whether impairment of large-scale network connectivity will prove to be a specific indicator of early AD. Our previous work with task-related fMRI strongly suggests that specific regions in the default network demonstrate impaired functional activity during memory processes in MCI and AD (Celone 2006; Pihlajamaki Specific Aims Page 89 Principal Investigator/Program Director (Last, first, middle): Sperling, Reisa, Anne 2008). Similar to resting fMRI data, these task-related functional alterations are sometimes seen in normal older controls (Miller 2008), however, our recent preliminary data suggests that amyloid deposition may underlie these functional abnormalities in asymptomatic individuals with high amyloid burden (see Section 12.3). The overall goals of the proposed research are to investigate whether disrupted functional connectivity (fc-MRI) at rest is indicative of impaired functional responses during memory challenges (task-fMRI), and to determine if fcMRI and task fMRI measures demonstrate a similar relationship to cognitive impairment and occult amyloid pathology. We will explore whether specific networks demonstrate differential levels of impaired connectivity in aging compared to AD. The anatomic overlap between the default network and amyloid deposition has been previously noted (Buckner 2005). Our recent work suggests that regions with high degrees of cortical connectivity, such as prefrontal regions, are selectively vulnerable to amyloid deposition, even outside of the default network (Buckner 2009a). In addition, it is likely that cerebrovascular disease contributes to frontoparietal network dysfunction in aging, and may interact with AD pathology to hasten clinical decline (van Straaten 2008). The combination of fc-MRI and task-fMRI may serve to elucidate the differential involvement of fronto-parietal attentional networks and default-memory networks in aging vs. early AD. We will acquire fc-MRI data during the same session as task-fMRI data in a large group of older subjects (total N=180) across the continuum from normal aging to MCI and mild AD, being followed in the candidate’s currently funded research projects. A subset of these subjects will undergo PiB-PET amyloid imaging as part of the R01 supplement, and we will be able to relate fc-MRI to amyloid burden in these subjects. We will relate fc-MRI data to task-fMRI data in these subjects, in order to accomplish the following aims: Aim 1: To determine if resting functional correlations between key regions of the distributed memory networks is predictive of objective memory performance across a continuum of cognitive impairment from normal aging to mild AD. Aim 2: To investigate whether the degree of resting connectivity between the hippocampus, inferior prefrontal regions and the precuneus/posterior cingulate (PPC) is related to the degree of hippocampal and frontal activation and PPC deactivation during task-related fMRI. Aim 3: To investigate whether amyloid deposition in the PPC and frontal regions are related to impaired connectivity in older subjects with cognitive impairment. Hypotheses: We hypothesize that resting fc-MRI will relate to both memory performance and task-related fMRI activity in older subjects with varying degrees of cognitive impairment. Furthermore, although frontoparietal fcMRI measures will be impaired even in cognitively normal subjects without amyloid pathology, the presence of amyloid deposition in the PPC will be associated with specific disruption of connectivity between the PPC and hippocampal regions. In more impaired subjects, this disconnectivity will also relate to hippocampal and entorhinal atrophy. Opportunities for Mentee Involvement: Several of my current mentees are interested in functional connectivity and network dysfunction in aging, MCI, and AD. One mentee has already started to work with fc-MRI using pilot data in normal older subjects (Wang Under Revision; see 12.3).